Development of isogenic iPSC cell lines expressing tauopathy-related PERK risk variants to study homeostatic control of protein levels during ER stress

Project Summary
In neurodegenerative diseases, accumulation of misfolded proteins is the pathological hallmark. Levels of the
toxic proteins, such as tau, correspond to cellular dysfunctions and cause neurodegeneration. Protein levels
are normally carefully maintained by the balance of the synthetic and degradative pathways. However, how
the steady state is orchestrated between the different pathways is not clear. One protein that is dysregulated
in neurodegenerative diseases is the microtubule-binding protein tau. For example, tau levels are elevated in
the Alzheimer’s disease post-mortem brain, and this correlate with pathology and clinical signs. One candidate
that may be able to coordinate multiple pathways, controlling both production and degradation of tau, is PERK
(protein kinase R (PKR)-like endoplasmic reticulum kinase). PERK is an endoplasmic reticulum (ER) resident
protein, and is activated during ER stress. The identification of a PERK risk variant for tauopathy in multiple
large GWA studies underscores the importance of understanding the ways that PERK controls protein
homeostasis in health and in disease. Using human induced pluripotent stem cell (iPSC) lines carrying a
PERK risk variant (PERK B) associated with tauopathies, the authors made the discovery that ER stress leads
to an elevation in tau levels and neuronal death. PERK B contains three coding-region SNPs resulting in
nonsynonymous missense mutations at amino acid positions 136, 166 and 704. It was found that PERK B is a
functional hypomorph; its kinase activity is reduced via the S704A mutation. Additionally, during ER stress
triggered by tunicamycin, tau protein levels, instead of being reduced, are increased in the homozygous risk
variant (PERK B/B) compared to the control (PERK A/A). These data suggest an alteration in tau protein
homeostasis caused by PERK B, but the involvement of other genes could not be ruled out, because the
PERK B/B and PERK A/A iPSC lines were not isogenic. This proposal seeks to test the hypothesis that PERK
B dysregulates protein homeostasis, via changes in protein production and/or clearance. Aim 1 proposes to
generate isogenic lines from iPSC carrying PERK A/A to B/B and B/B to A/A. The mechanisms of tau
homeostatic dysregulation during ER stress will be investigated by performing protein translation poly-
ribosome and SUnSET assay and protein degradation cycloheximide chase assay. Trazodone, a PERK
activator which is proposed as a therapeutic agent for neurodegeneration, will be tested to determine its effect
on PERK A/A and B/B genotypes. The results of this proposal will provide improved lines and cell model
system to examine regulation of homeostasis of tau and proteins in general during ER stress. This proposal is
suitable for the R03 mechanism, for the results will provide the support for the preparation of a future R01
submission.

Public health relevance
Project Narrative The proposed project is relevant to public health because it aims to investigate how toxic proteins, which are pathological hallmarks of dementia, accumulate in the brain cells. The proposed research is in alignment with the mission of the National Institute of Aging to improve the health and well-being of older Americans.